Understanding Innate Immune Recognition and IFN-g-Mediated Immunity in Cryptosporidiosis

PROJECT SUMMARY
Cryptosporidiosis, a disease caused by the protozoan parasite Cryptosporidium, poses a significant global
health threat, particularly affecting young children in developing regions and immunocompromised individuals.
Despite its severity, there are currently no vaccines or effective therapies available, highlighting the urgent
need for innovative solutions.
This research proposal addresses this critical gap by focusing on two key objectives: establishing reliable small
mouse models of cryptosporidiosis and unraveling the intricacies of IFN-γ responses during C. parvum
infection. Our preliminary data underscore the significance of the TLR11/TLR12 complex in detecting
Cryptosporidium and regulating IFN-γ-mediated immune responses. Additionally, we have developed mouse
models with cell-specific deficiencies in IFN-γ production and responsiveness, providing valuable tools to
enhance our understanding of host defense against Cryptosporidium.
The primary objective of this project is to elucidate the fundamental pathways governing the host's ability to
combat C. parvum infections at mucosal sites. To achieve this, our research is structured around specific aims
that explore the roles of TLR and IFN-γ pathways in mucosal immunity. This knowledge will provide insights
into the molecular and cellular responses that ultimately determine the outcome of C. parvum infections at
mucosal sites. Our research endeavors aim to contribute to the development of innovative strategies to combat
this devastating disease.

Public health relevance
PROJECT NARRATIVE This research aims to establish robust mouse models for cryptosporidiosis and investigate the complexities of IFN-γ responses, ultimately contributing to innovative strategies for combatting this pressing global health threat.